Administrative Core

The MAVDA Administrative Core (MAC) will be established as an integrated, priority-setting consortium
involving the Program Directors (PDs), a Business Director (BD), an internal MAVDA Leadership Team (MLT),
and a Scientific Advisory Board (SAB) with programmatic involvement from NIAID to enhance potential product
outcome in the form of antivirals against SAR-CoV-2 and other viruses with pandemic potential. The
management function is designed to provide administrative support that facilitates the success of individual
projects, promotes effective integration and allocation of support functions and resources, and stimulates
scientific exchange between MAVDA members, thus ensuring that the overall program achieves its objectives.
The MAC will be overseen by co-PDs, Dr. David S. Perlin and Dr. Charles M. Rice, who will be supported by an
experienced BD and appropriate support staff to coordinate and manage all administrative functions. To best
advance MAVDA's objectives, the MAC will coordinate regular meetings of Project Leaders, Pharma/Biotech
Partners, Core Directors, and SAB members. The meetings are designed to advance compounds through the
discovery matrix enabling timely and objective ‘Go/No Go’ decision making. A secure web-based platform will
be used to foster interactions between Projects and Cores. The MAC will facilitate an annual review meeting with
the SAB, and a reverse site visit at NIAID. It will produce and submit the annual progress report to the NIH, and
it will coordinate research publications, meeting presentations, reports and press releases. MAVDA is designed
to encourage partnering among academia and industry, specifically Pharma and Biotech companies, and has
protections in place to protect the intellectual property of participating organizations. There is universal
confidentiality between projects and cores, with data shared as required to advance compounds and at no risk
to the project team. As MAVDA retains no IP rights, all IP rights reside in the host institutions or per agreements
with industry partners. The MAC will execute the following Specific Aims: 1) establish a highly efficient
management structure that supplies essential oversight and guidance for Project Leaders and Core Directors,
effectively integrates the Scientific Advisory Board as strategic advisors in the discovery process, and promotes
scientific exchange; 2) maximize allocation of resources and prioritize compound development by establishing
critical metrics for ‘Go/No Go’ decision making and resource allocations by supporting close interactions of
Project Leaders and Core Directors and scheduling regular reviews; 3) annually assess project performance and
prepare interim and year-end reports; 4) solicit and manage Developmental and Mentored Research Projects;
5) coordinate publications, presentations of results, and press releases from these studies and develop a
managerial plan for conflict resolution and other operational issues; and 6) establish an internal organizational
structure that addresses logistics for material transfer agreements, intellectual property filings, licensing
opportunities, and negotiations.